PHASE 1 TRIAL FOR A THERAPEUTIC MONOCLONAL ANTIBODY FOR CHIKUNGUNYA VIRUS

The Early Phase Clinical Trial Units provide a vehicle for investigation of new agents in the treatment and prevention of infectious diseases, and can carry out all aspects of interventional clinical trial implementation.